Digital Phenotyping of Early Development in Neurogenetic Conditions

PROJECT SUMMARY/ABSTRACT
This R01 application proposes to use a novel telehealth-based assessment protocol to collect high quality
clinical, behavioral, and electrophysiological assays to characterize early course and predictors of clinical
outcomes among young children with rare neurogenetic conditions (NGCs). Characterizing the earliest
development of children with NGCs, including predictors of common comorbidities, is essential to developing
evidence-based standards of care, identifying clinical treatment targets, and designing effective support
programs. However, the assessment tools needed to monitor the early development of NGC patients are
severely lacking, particularly for young children with severe sensorimotor or cognitive impairments. To address
these gaps, PI Kelleher developed PANDABox (Parent Assisted Neurodevelopmental Assessment;
K23MH111955), an open science, telehealth-based assessment protocol for collecting high quality, integrated
clinical, behavioral, and spectral assays (e.g. heart activity, vocal patterns) from children with rare disorders. In
contrast to standard neuropsychological assessments, PANDABox includes a series of classic “laboratory tasks”
that are appropriate for a wide spectrum of abilities and are administered by caregivers in the family home. Now,
what is lacking is a large corpus of natural history data, collected using PANDABox, that can be harvested to
identify the most valid, reliable, and feasible assays for clinical monitoring of NGCs. To address this need, the
present proposal will deploy PANDABox in a large, cross-syndrome, longitudinal cohort of young children with
NGCs to generate a large corpus of natural history data that will be used to identify reliable and valid assays that
distinguish early developmental profiles in 6-42 month old children with and without rare NGCs, and that predict
variability in community-prioritized clinical outcomes. If funded, this project will improve the human condition by
deploying accessible, patient-centered telehealth assays that have potential to radically shift the status quo for
developmental surveillance in young NGC patients, including those who are geographically distributed or
marginalized, setting the stage for improved clinical outcomes for children with NGCs and their families.

Public health relevance
PROJECT NARRATIVE Accurately monitoring the early development of children with neurogenetic conditions is critical to understanding typical and atypical trajectories, and to developing standards of care and supports that optimize patients’ quality of life. However, the assessment tools needed to conduct these studies are severely lacking, particularly for young children, those with severe sensorimotor or cognitive impairments, and those who are geographically distributed. The present proposal will use a novel remote assessment approach, developed through prior NIH funding for use in neurogenetic populations, to map the early developmental sequence of rare neurogenetic syndromes that lack early phenotyping data, setting the stage for improved clinical outcomes for children with NGCs and their families.